Interventions for Unemployed Hazardous Drinkers

DESCRIPTION (provided by applicant): Interventions for unemployed hazardous drinkers despite recent improvements in the US economy, unemployment remains a significant concern, and estimates indicate that one-third of unemployed persons drink at hazardous levels, adversely impacting their health and abilities to find jobs. Reinforcement interventions are highly efficacious in reducing substance use, and they can be applied to increase job-seeking activities as well. In partnership with CT United Labor Agency, this project is designed to reduce hazardous drinking and enhance active participation in job-seeking activities among those with job loss. It will evaluate the independent and combined effects of reinforcing negative breathalyzer samples and job-seeking activities to ascertain the simplest and most cost-effective approach to improving outcomes in this population. Unemployed individuals with hazardous drinking (N = 280) will be randomly assigned to one of four conditions using a 2 x 2 design: standard care, standard care with reinforcement for submitting negative breathalyzer samples, standard care with reinforcement for job-seeking activities, or standard care plus reinforcement for both negative breathalyzer samples and job-seeking activities. Participants in all conditions will receive usual services part of CT United Labor Agency, along with alcohol monitoring using a novel breathalyzer and cell phone video capture procedure. The study interventions will be in effect for four months, and participants will be followed for one year. Alcohol and other drug use, employment, psychiatric symptoms, and global measures of health will be assessed throughout treatment and follow-up. Reinforcing negative breathalyzer samples is expected to significantly reduce drinking, and reinforcing job-seeking activities is expected to increase re-employment rates and reduce time until job attainment. Reinforcing both negative breathalyzer samples and job-seeking activities is hypothesized to improve outcomes along both domains. The reinforcement interventions may also decrease psychiatric distress and slow progression of physical decline, common among the unemployed. If efficacious and cost- effective, results from this study may stimulate adoption of reinforcement interventions in the context of unemployment services. Reducing the adverse consequences of hazardous drinking and improving job re- entry may have pronounced benefits in a highly vulnerable segment of the US population.

Public health relevance
PUBLIC HEALTH RELEVANCE: Individuals who are unemployed drink at high rates, and heavy drinking can impact their ability to obtain and maintain jobs. Further, unemployed individuals have difficulties sustaining active job searches, which are critical for finding a job even during periods of economic downturn. This project will evaluate the independent and combined effects of novel interventions designed to reduce drinking and enhance job seeking efforts. If efficacious, these interventions may be ideally suited to reduce drinking and improve employment outcomes in the unemployed, a group with high morbidity and mortality.